Analysis of Metabolic Stress and Functional Integration in Prokaryotes

PROJECT SUMMARY
A fundamental feature of a living system is its integrated network of biochemical pathways that respond to
endogenous and environmental stresses. In humans, there is a strong connection between metabolic network
dysfunction and disease, while in microbes metabolic network structure dictates organismal capabilities,
including pathogenesis. Metabolic strategies are conserved across biology, and insights obtained from model
organisms provide the means to advance our understanding of general metabolic paradigms, which can often
be extrapolated to higher organisms including humans. The PI's laboratory utilizes a broad approach that
includes in vivo genetics, molecular biology, biochemistry, bioinformatics, proteomics, and metabolomics and
other global approaches to address timely questions in metabolism. In the long-term, the PI's research will
contribute to the understanding of the structure and integration of bacterial metabolic networks, how they
respond to perturbation, and how specialized capabilities (e.g., causing disease) are integrated into
metabolism. Reaching this vision will require the rigorous definition of metabolic components and their
integration, which together form the complex system of metabolism. Knowledge of fundamental metabolic
processes and a mechanistic understanding of functional components is critical to efforts aimed at treating
metabolic diseases, defining pathogenic strategies, and targeting metabolism for rational drug design,
synthetic biology, microbiome research, etc. Efforts in the next five years focus on, i) extending the
understanding of the RidA stress system, ii) comparing the endogenous stress systems of multiple microbes,
iii) identifying functions of additional Rid protein family members, iv) integrating results from these studies into
the metabolism of pyridoxal phosphate, and v) defining a function for the conserved YggS protein. Notably, the
human YggS homolog (i.e., PROSC) is a biomarker in B6 epilepsy in humans. The goals of this proposal will
be accomplished through a combination of chemical, biochemical, molecular genetics, bioinformatics and
global approaches. The work here is motivated by our desire to understand the complex system of metabolism,
specifically understanding metabolic stress generated by the production of reactive metabolites during growth,
how such stress can damage cellular components if not neutralized and discovering a unifying role for the
members of the broadly conserved Rid protein superfamily family.

Public health relevance
PROJECT NARRATIVE Metabolism describes the processes required for life in biological systems. Understanding the specifies of metabolism is essential for progress in biomedical fields, for instance, facilitating rational drug design and understanding antibiotic resistance. Our work contributes new, fundamental knowledge about the nature and behavior of living systems by defining a biochemical activity and metabolic role for conserved proteins of unknown function, one of which is a disease marker in humans.